Human Agency and Brain-Computer Interfaces: Understanding users’ experiences and developing a tool for improved consent

Project Summary Neural prosthetic devices for sensorimotor and psychiatric disorders are in development as a priority area of the BRAIN Initiative yet they raise important ethical concerns about human agency. Agency, our ability to act and to take ownership of our thoughts and actions, is central to individual identity and moral responsibility. Although concerns about agency are often raised in the literature on neural prosthetics, agency remains a complex phenomenon that is (1) poorly understood, (2) difficult to study through quantitative or one-off qualitative “outsider” methods, and (3) without resources to help research participants understand agency side effects and engage in meaningful informed consent. In this project, we aim to address these gaps. We will (1) conduct a comprehensive survey of the relevant literature on agency and neurotechnology in order to construct a concept map of neural agency, (2) use a longitudinal and phenomenological interview method to better understand and explore user perspectives on agency, and integrate those perspectives into a user-centered neural agency framework, and (3) develop a communication tool (a question prompt list or QPL) that research participants and patients can use to understand and discuss potential agency effects of neural devices during the informed consent process. This project is innovative in its assessment of agency across four types of neural prosthetic modalities: communication, sensory, motor, and psychiatric devices. It utilizes a novel method of longitudinal and phenomenological interviews accomplished by embedding ethicists in neural engineering labs, creating the close, collaborative relationships between scientists and ethicists needed for the ethical development of neural technologies. The transdisciplinary and international team assembled for this project has the knowledge, experience, and expertise to successfully complete this project. This project will provide knowledge about human agency that can be incorporated into a QPL tool for improved informed consent for neurotechnology research.

Public health relevance
Project Narrative Neural prosthetic devices (brain computer interfaces or BCIs) are being developed for a wide range of human diseases and conditions. These devices may affect users’ sense of agency. This project will explore how users experience agency and will use this information to improve informed consent practices.